Development of an MRI Guided Machine Learning Algorithm to Assess the Velopharyngeal Mechanism

PROJECT SUMMARY
More than 25-35% of children with velopharyngeal (VP) or palatal anomalies, such as those associated
with repaired cleft palate and/or craniofacial conditions, will develop velopharyngeal dysfunction (VPD) as
evidenced by hypernasal speech. This can negatively impact quality of life and communication abilities across
the lifespan if not corrected during childhood. VPD often requires surgical management to achieve an anatomy
capable of producing normal speech and balanced resonance. However, an extremely high failure rate (up to
32%) is reported for these surgical procedures, and numerous revision surgeries are necessary. With each
revision surgery, the likelihood for success further decreases. Furthermore, although the consequences of VPD
are well established, the fundamental anatomic underpinnings for what constitutes functional VP anatomy from
non-functional anatomy is poorly understood due to the inability for clinicians to objectively quantify the VP
mechanism and consider patient-specific variables in the pre-operative assessment process.
Recent work utilizing MRI has emerged as a methodology to facilitate improved understanding of the VP
anatomy. However, previous efforts to understand the VP mechanism have been significantly limited by small
sample sizes and time-intensive analytic methods. What is needed is a major technological advancement in our
ability to quantify the VP anatomy and utilize this information to integrate patient-specific measurements into the
clinical decision-making process.
The main objectives of this R21 project are to deliver a cutting-edge, artificial intelligence/deep learning
framework for automated 3D segmentation and 2D measurement of VP structures (Aim 1), to develop a large
dataset to test foundational hypotheses on the relationships between velopharyngeal anatomy and speech
resonance (Aim 2), and assess feasibility for integration of anatomic analyses in a clinical workflow (Aim 3).
These advancements will lay a critical foundation by developing a clinically feasible method for accurate, pre-
operative assessment of the VP mechanism, which will accelerate clinical translation and development of precision
medicine approaches. This will lead to exciting opportunities for patient-specific surgical planning and operation
with a higher success rate. This will ultimately improve communication outcomes and quality of life for children
with VPD.

Public health relevance
PROJECT NARRATIVE Velopharyngeal (VP) anomalies, often associated with cleft palate and other craniofacial conditions, can have a substantial impact on speech and communication abilities as well as overall quality of life if unsuccessfully repaired. This investigation will provide the foundation for a successful line of focused, translational research to improve clinical assessments and speech outcomes in children born with VP anomalies as well as reduce the need for subsequent revision surgeries by developing a method for automated, pre-operative, objective, patient- specific anatomic assessment. The results of this proposal will directly contribute to NIDCD’s mission to improve the health of children with speech and resonance disorders associated with velopharyngeal dysfunction by enabling a high impact collaboration between speech physiology, craniofacial/plastic surgery, data science, and biomedical engineering, particularly in the area of precision medicine, to improve speech and surgical outcomes for children with cleft/craniofacial conditions.